The impact of Alzheimer's disease on novel genetic signatures of hippocampal memory traces

PROJECT SUMMARY / ABSTRACT
Memory loss is a devastating symptom of age-related neurodegenerative disorders such as Alzheimer’s disease
(AD). Memories are thought to be stored in the brain in neural ensembles called engrams, which are traces of
individual memories that are active during both memory encoding and memory retrieval. In a mouse model of
AD, prior research has shown that the APP/PS1 mice are impaired in retrieval of a contextual fear conditioning
(CFC) memory, and this memory deficit is paralleled by impaired engram reactivation. While past studies have
identified and manipulated these ensembles in the context of AD, researchers have not fully elucidated the
molecular changes occurring in engram cells that contribute to this memory deficit. This proposal addresses this
gap in knowledge by determining the gene expression landscape that distinguishes engram cells from non-
engram cells in the HPC, and how this landscape changes with age and AD. These experiments will use cutting-
edge labeling techniques and single-nuclear RNA sequencing (snRNA-seq) to test the hypothesis that engram
cells show transcriptional signatures unique from those of cells active during memory encoding or retrieval alone,
that these signatures are required for proper engram reactivation, and that they are lost in APP/PS1 mice. Aim
1A uses an intersectional transgenic approach with the activity-dependent labeling mouse line ArcCreERT2 x
Sun1-GFP to indelibly tag nuclei of cells active during memory encoding and retrieval. HPC tissue will be
dissociated, sorted via flow-activated nuclear sorting (FANS), and profiled via snRNA-seq to compare encoding-
active, retrieval-active, and reactivated engram cells. In Aim 1B, select highly differentially enhanced genes
(DEGs) in reactivated engram cells will be validated by fluorescence in situ hybridization (FISH), then artificially
knocked down via virally induced RNA interference (RNAi) to test whether these key targets are necessary for
engram reactivation and subsequent memory retrieval. Lastly, Aim 2 uses a similar tagging strategy and
behavioral paradigm in 6-month-old APP/PS1 (+ or -) x ArcCreERT2 x Sun1-GFP mice to determine how engram
transcriptomes diverge between control and disease states. This experiment tests the hypothesis that engrams
of APP/PS1 mice lack the signatures that define engrams in age-matched controls, underlying their deficit in
memory performance. Successful completion of these aims will illuminate with unprecedented resolution how
memories are stored in the HPC and how they change with AD, unveiling a suite of key molecular players that
are critical to memory storage and may serve as therapeutic targets. The training plan of this proposal includes
several novel technical skills, including stereotaxic surgery, in situ hybridization, RNAi-mediated knockdown, and
advanced bioinformatic analysis. Additionally, it describes myriad professional scientific skills such as
grantsmanship, scientific writing, and oral presentation that will be fostered in the richly collaborative research
environment of this application, setting the stage for a successful independent research career.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is a debilitating and irreversible neurodegenerative disease associated with major disruptions to memory. While memories are thought to be stored in engrams, or ensembles of neurons throughout the brain that are necessary and sufficient for memory expression, it is unknown what biophysical changes occur in these individual engram cells and whether their disruption drives AD-associated memory loss. Here, I will identify and manipulate molecular signatures unique to engram cells in the hippocampus (Aim 1) and assess how these signatures are altered in a mouse model of AD (Aim 2) in order to identify novel molecular targets for AD-associated memory loss.